Creating a transient metabolic catastrophe for AML therapy

Proteasome inhibitors are effective in a small subset of malignancies, the most important one is multiple
myeloma, a cancer of plasma cells. The underlying reasons for the exquisite sensitivity of myeloma to
proteasome inhibitors are associated with the activation of higher stress conditions that ultimately promote
apoptosis. Similar to myeloma, acute myeloid leukemia (AML) develops in the bone marrow and disseminates
between bone marrows until becomes detectable in the bloodstream. The bone marrow microenvironment
supports AML survival and promotes resistance to therapy. We have shown that a common feature associated
with proteasome inhibition in vitro and in vivo is the suppression of mTORC1 activity, a kinase that controls cell
metabolism and activation thereof is common to multiple cancers, including AML and myeloma. We reasoned
that mTORC1 suppression is a key factor in promoting survival to proteasome inhibition and contributes to
development of resistance. We developed a small molecule that activates mTORC1 and synergizes with PIs to
kill AML in vitro and in vivo. When the molecule is combined with a proteasome inhibitor, mitochondrial respiration
is strongly suppressed, and the membrane potential of the mitochondria is gradually lost. When the mTORC1
activator is added to quiescent AML cells, cell cycle resumes, and the cells regain sensitivity to chemotherapy.
We will study the underlying mechanisms of both phenomena, mitochondrial damage, and reversal of
quiescence. We will map the mitochondrial respiratory lesion, identify the predisposition of the mitochondria to
stress and establish a connection with drug resistance. We will determine the translation mechanisms that
reverse quiescence and evaluate the importance to AML therapy using in vitro and in vivo models. This study
aims to establish a mechanistic understanding of the role of mTOR hyperactivation as a chemosensitizer of AML.
These pharmacodynamic features should unravel novel metabolic vulnerabilities in AML that can be addressed
pharmacologically.

Public health relevance
Narrative We are introducing the novel concept that mTORC1 activation prevents the adaptation of AML to proteasome inhibitor therapy and breaks leukemic cell quiescence. We propose that mTORC1 activation predisposes the mitochondria to undergo a functional shutdown in the presence of proteasome inhibitors and additional chemotherapy. We will study the underlying mechanisms in vitro and in vivo using a novel mTOR activator that we termed AcTor.